DOPAMINERGIC VARIANTS INVOLVED IN SMOKING BEHAVIOR: A PERFUSION FMRI STUDY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. This R21 project utilizes ASL perfusion fMRI, smoking behavioral assays and a functional candidate gene association approach of dopaminergic addictions-targeted polymorphisms to examine the brain and behavioral activity of smokers under conditions of satiety and withdrawal during exposure to smoking reminders.